Improving the prediction of opioid outcomes via automated EHR data processing

PROJECT SUMMARY/ABSTRACT
This K01 proposal aims to develop and validate an AI-driven framework to efficiently predict and identify severe
opioid adverse drug effects (ADEs), including persistent use and related post-surgical outcomes from electronic
health record (EHR) data. EHR data are often compromised by inconsistencies, missing values, and outliers,
which undermine accurate risk prediction. Traditional data processing methods face human-related limitations
such as resource demands, biases, and insufficient domain expertise. This project addresses these issues by
leveraging automated machine learning (AutoML), knowledge graphs (KGs), and generative AI to enhance data
cleaning and feature engineering processes. Building on my prior experience and research in machine learning
and clinical data analysis, the proposed training plan will capitalize on an exceptional mentorship team and
translational research environment to foster the candidate's expertise in 1) expanding AutoML to perform EHR-
specific data cleaning, 2) developing comprehensive digital KGs enriched with domain knowledge to optimize
data processing, and 3) leveraging large language models for human-AI collaborative feature engineering,
refinement, and discovery. The proposed research will use EHR records of over 6,000 elective spinal fusion
patients and later expand to include external and publicly available datasets. The AutoML tool, STREAMLINE,
will be enhanced with custom operators for data cleaning to resolve anomalies, guided by a KG enriched with
EHR and addiction medicine expertise (Specific Aim 1). A large language model, integrated with retrieval-
augmented generation, will enable human-AI collaboration to streamline past medical history feature engineering
and identify novel opioid ADE predictors (Specific Aim 2). The combined impact of these methods will be
evaluated on simulated and real-world retrospective and prospective datasets (Specific Aim 3). The central
hypothesis is that AutoML-KG data cleaning, together with human-AI feature engineering, will improve predictive
performance, data quality, and model interpretability. The project will result in development of scalable,
interpretable, and clinically relevant automated computational tools for opioid ADE prediction, enabling broad
implementation across diverse healthcare systems. The proposed research will take place at Cedars-Sinai
Medical Center under the mentorship/collaboration of Drs. Jason Moore, Ryan Urbanowicz, Corey Walker, Itai
Danovitch, Joshua Pevnick, and Tiffani Bright, experts in ML/AI methods, predictive modeling, neurosurgery,
addiction medicine, biomedical informatics, and healthcare ethics, respectively. The research and training
expertise developed through this K01 award will support the PI's career development as an independent
investigator and leading expert in AI-driven prediction of severe opioid ADEs and associated clinical outcomes.
Findings will inform an R01 aimed at developing personalized risk assessment strategies incorporating complex
data types (e.g., omics, social media, and unstructured clinical notes) to investigate multilevel determinants of
opioid misuse, tolerance, opioid use disorder, and overdose.

Public health relevance
PROJECT NARRATIVE Severe opioid adverse drug effects (ADEs), including persistent use, tolerance, and opioid use disorder (OUD) remain significant public health challenges, yet risk identification is often hindered by inconsistencies in electronic health record (EHR) data and human data processing limitations. This project aims to overcome these issues by developing an artificial intelligence (AI)-driven framework that leverages automated machine learning, knowledge graphs, and large language models to improve and standardize EHR data quality. Through human- AI collaboration, this approach will optimize data cleaning, streamline feature engineering, and uncover novel ADE risk factors, ultimately improving clinical decision-making and facilitating personalized risk assessments.